Developmental Origins of Endocrine Dysfunctions

DESCRIPTION (provided by applicant): The postdoctoral Pediatric Endocrinology and Diabetes Training Program at the University of Michigan is designed to recruit and provide high quality research training in one of two major tracks, Basic Science or Clinical Investigation &Epidemiology to qualified candidates. The theme of the Program is developmental programming of endocrine disorders. The program is organized to complement the established training program in clinical pediatric endocrinology for M.D.s, and for basic scientist pursuing a career in endocrine research, by providing 2 years of intensive postdoctoral training using closely-mentored research training program individialy structured for each trainee. The program is actively supported by 19 faculty from 12 different departments, all of whom have extensive research and mentoring experience. The Program also includes an extensive didactic component tailored to each trainee's educational background and research interests. Trainees in the Basic Sciences complete a 3-month course designed to expose them to a variety of state-of-the-art techniques, as well as to skills in performing hypothesis-driven, controlled research studies. Trainees in the Clinical Investigation &Epidemiology choose between Outcomes &Epidemiology or Clinical Research. They complete courses leading to either a Master of Public Health in Biostatistics &Epidemiology or a Master of Science in Clinical Research Design &Statistical Analysis. In addition to the formal curriculum, trainees attend weekly clinical and research seminars. Mentored research is supported the Medical School resourses including the Centers of Integrative Genomics, Proteomics, Organogenesis and Diabetes and the Center for Advancement of Clinical Research. To optimize each trainee's potential for development of a successful academic career, trainees are required to submit abstracts to national meetings, submit a first-authored research manuscript, and apply for individual grant funding. Expansion of our Program will help alleviate the critical shortage of successful Pediatric Endocrinologists and Pediatric Physician-Scientists